Large-scale Production &Purification Of Compounds With

The Biotechnology Unit is responsible for the production and purification of biological material. The Unit undertakes a wide array of biological production tasks such as large scale growth of prokaryotes and eucaryotes, and production and purification of biological compounds especially proteins. These products, not available from commercial sources, are needed for clinical and structural studies. The Biotechnology Unit is capable of handling these various production tasks by implementing both physiological and technical approaches. Efficient process development and production is possible since the Unit possesses two integrated elements: a fully operational multi purpose pilot production facility and the capability of conducting research and process development. During the last year the unit performed approximately 200 different, large scale preparations including: 1) growing various microorganisms such as recombinant Escherichia coli, recombinant Pichia pastoris, mutant strains of Corynebacteria diphtheria, several types of Salmonella and Shigella, Staphylococcus strains and mutant strain of Bacillus anthracis; 2) propagating large volumes of various eucaryotic cells such as HeLa, CHO, drosophila, Sf 9 and hi five; 3) purifying gram quantities of diphtheria toxin CRM 9 (Cross Reacting Material), recombinant Pseudomonas aeruginosa exotoxin A, protective antigen from Bacillus anthracis. Staphylococcal enterotoxin type C, experimental transmission blocking vaccine for malaria and several antibodies both from hybridoma culture and rabbit serum. On the research and development arena, the unit continues its work in the following topics: 1) development of more efficient methods for large scale protein recovery, here we continue our work on implementing expanded bed adsorption techniques for capturing proteins on ion exchangers, and hydrophobic resins, utilizing new types of expanded column this column does not have flow adaptors and screens and therefore can handle larger concentration of biomass at higher low rates; 2) conducting research aimed at understanding the glucose metabolism of various recombinant E. coli strains in an effort to find out why certain strains are more suitable for foreign protein production using microarrays technology and protein analysis; 3) developing fermentation procedures for expressing sensitive, recombinant clostridium protein from E.coli by implementing anaerobic growth conditions; 4) conducting experiments for improving the production protocol of recombinant proteins from Pichia pastoris, especially experiment malaria transmission blocking vaccine; 5) the unit started another research project associated with mammalian cells, trying to understand the genetic difference between cells that can grow in suspension, and cells that are anchorage dependent. In addition, the unit continues its research work on the production process of recombinant proteins from the HeLa/vaccinia system, In collaboration with LDMI, NICHD, the unit conducted work on the development of new vaccine against Shigella flexneri and Bacillus anthracis, the products are currently in field trials.